Estrogen Receptor-alpha Effects on Right Ventricular Vascular Density and Angiogenesis in Pulmonary Hypertension

Pulmonary hypertension (PH) and right ventricular (RV) dysfunction are extremely common in veterans. Up to
80% of veterans with chronic obstructive pulmonary disease, pulmonary fibrosis, sleep disordered breathing or
LV dysfunction (either systolic or diastolic) suffer from PH. Better RV function and female sex have been linked
to improved survival in PH, and female patients exhibit better RV function than their male counterparts. This
proposal builds on two successful funding periods and the scientific premise that even though RV function and
female sex are major determinants of survival in PH, no RV-specific or sex steroid-directed therapies exist. RV
endothelial cell (RVEC) dysfunction and impaired angiogenesis play a major role in the development of RV
failure, and data obtained in the previous funding period demonstrate that the female sex steroid 17-estradiol
(E2) increases capillary density in the RV and stimulates angiogenesis in cultured RVECs. The goal of this
proposal is to identify novel and therapeutically targetable mechanisms by which E2 exerts protective effects on
RVEC function in PH. We provide evidence that in RVECs, E2 increases expression of the enzyme carnitine
palmitoyltransferase 1a (CPT1a), a rate-controlling enzyme of fatty acid oxidation (FAO) responsible for
importing fatty acids into the mitochondria. We suggest a new mechanism by which E2, via its receptor ERα,
enhances FAO in RVECs to increase their angiogenic function, thus leading to increased RV resilience and
better adaptation to increased afterload. Based on these findings, we now put forward the novel hypothesis that
E2 improves RV function in PH by ERα- dependent up-regulation of RVEC CPT1 and FAO. We propose the
following specific aims: 1) To determine whether ERα is necessary for E2 to increase CPT1a expression and
activity and to stimulate FAO in RVECs, 2) To identify transcriptional regulators employed by E2 to regulate FAO
in RVECs, and 3) To establish that the ERα-BMPR2-apelin axis in RV cardiomyocytes (RVCMs) enhances
CPT1a expression, FAO, and angiogenesis in RVECs. In the prior funding period, we generated a novel ERα
loss-of-function rat model that we will now employ to study the role of this receptor in modulating FAO in RV
failure. We will complement in vivo studies in clinically relevant models of RV failure with mechanistic
experiments in RVECs isolated from rodents with RV failure and from patients with compensated (adaptive) or
decompensated (maladaptive) RV hypertrophy. Endpoints investigated will include RV function and structure (by
pressure volume loops and echocardiography), exercise capacity (measured as VO2 max via treadmill running),
RV capillary density (quantified using unbiased stereology and lectin staining), angiogenesis assays (matrigel
tube formation and transwell migration), comprehensive metabolic assessments with interrogation of all major
steps of FAO and use of high-throughput metabolomics, and the assay for transposase-accessible chromatin
using sequencing (ATAC-seq) followed by transcription factor enrichment analysis (TFEA). The proposed studies
are significant, since they will 1) identify the E2-ERα axis as a critical modulator of RVEC metabolic function, 2)
identify novel transcription factors engaged by E2-ERα, and 3) establish a novel and therapeutically targetable
E2-ERα-CPT1a-FAO axis in RVECs. The proposed studies are innovative, since they, for the first time, will
identify FAO modulation as a molecular basis for E2’s RV- and RVEC-protective effects in PH, and since they
will identify E2- ERα-signaling in RVCMs as a novel modifier of RVEC metabolism and angiogenic function. In
addition, they provide technical innovation through use of high-throughput, mass spectrometry-based
metabolomics and ATAC-seq with TFEA. Upon completion of the proposed studies, we will have identified E2-
ERα signaling and its targets as novel mediators of FAO and adaptive signaling in RVECs. This may ultimately
allow for the development of new RV-directed, non-hormonal treatments for both female and male veterans with
PH and RV failure.

Public health relevance
The proposed research is relevant to the health of veterans because it will determine novel mechanisms that lead to the development of pulmonary hypertension (PH) and right heart failure (RHF). While PH and RHF affect millions of people worldwide, veterans, due to their demographics and comorbidity burden, are at particular risk for the development of these conditions. In addition, once they develop PH and/or RHF, veterans are at high risk for poor outcomes such as hospital admissions and death. The risk for poor outcomes is particularly high in male veterans. The goal of this proposal is to better understand the role of 17E-estradiol (E2) and its downstream signaling targets in modulating endothelial cell metabolism and endothelial cell resilience in the right heart. This will allow for the development of novel treatment strategies to protect the right heart in PH. The proposed work is relevant to the mission of the VA, since it will lead to the development of novel treatments for both male and female veterans with PH and RHF.